Sensing Technologies for Maternal Depression Treatment (StandStrong)

PROJECT SUMMARY/ABSTRACT
There is a high global burden of untreated postpartum depression. Untreated postpartum depression presents
acute and long-term risks to a mother’s mental and physical health, as well as her child’s survival, health, and
development. Although there is increasing willingness among funders and health systems to involve nonspecialists, such as community health workers, in the delivery of psychological interventions for postpartum
depression, the outcomes of these non-specialist interventions have been mixed. Digital technology, specifically
the use of passive sensing data collection to learn more about a mother’s life and support behavior change, has
the potential to improve the effectiveness of psychological interventions delivered by non-specialists. For the
proposed R21/R33, we will build on preliminary development work of Sensing Technologies for Maternal
Depression Treatment (StandStrong) to demonstrate feasibility, acceptability, and functionality for postpartum
depression treatment. StandStrong is a digital platform consisting of two mobile apps, internet-of-things (IoT)
passive sensors, and a data analysis engine built using modern machine learning approaches. StandStrong
incorporates passive sensing data collection from mothers and their infants that can be monitored by nonspecialist counselors and then incorporated to better personalize psychological treatment. For Aim 1 (R21
phase), we will use human-centered design to iteratively refine the StandStrong platform and associated
implementation material. For Aim 2 (R21 phase), we will evaluate the StandStrong platform and associated
contents according to acceptability, feasibility, usage, benefit, and validity. If milestones are met for the R21, we
will proceed to the R33 stage. In the R33 stage, for Aim 3 we will conduct a pilot randomized controlled trial
(RCT) comparing a psychological treatment as usual with the psychological treatment supplemented by the
StandStrong passive sensing platform with 112 depressed mothers (56 in each arm). For Aim 4 of the R33
phase, we will identify parameters for sustainability and scalability, as well as costing the intervention, to
ultimately prepare for a fully-powered RCT in the United States with future R01 funding. Successful completion
contributes to the NIMH’s 2020 Strategic Plan to tailor existing interventions and develop innovative service
deliver for mental health interventions. This project will contribute to NIMH’s Opportunities and Challenges of
Developing Information Technologies through improving treatment of mental health conditions through use of
passive sensing technologies.

Public health relevance
PROJECT NARRATIVE Untreated postpartum depression impacts maternal morbidity and mortality and has long-term impacts on children's survival, mental and health physical health, and development. We will refine development of a digital platform that can be used by non-specialists to improve delivery of psychological interventions for postpartum depression by incorporating passive sensing data collected from a mobile phone and passive Bluetooth beacon with the mother and her infant. Successful completion of this study will lead to a full trial of the digital platform, and contribute to NIMH goals of digital phenotyping and promoting scalable interventions.